Elucidating the mechanisms by which ectopically expressed genes and piRNAs perturb somatic cell function when histone methylation is inappropriately regulated

PROJECT SUMMARY
Kabuki-like syndrome is a neurodevelopmental disorder caused by mutations in the H3K4 demethylase, LSD1,
and is characterized by a range of abnormal somatic phenotypes including intellectual disabilities, craniofacial
abnormalities, and developmental delay. Despite their implication in Kabuki-like syndrome, and other
neurodevelopmental syndromes, how mutations in histone modifying enzymes like LSD1 contribute to complex
developmental phenotypes is unclear. To better understand how mutations in histone modifying enzymes affect
somatic development we have developed a C. elegans model lacking SPR-5, the C. elegans ortholog of LSD1,
in addition to the histone 3 lysine 9 (H3K9) methyltransferase MET-2. Without SPR-5 and MET-2, progeny
ectopically express germline genes in somatic tissues leading to phenotypes that resemble those observed in
neurodevelopmental syndromes, including muscle defects and developmental delay. Strikingly, the
developmental delay and ectopic expression of candidate germline genes in spr-5; met-2 mutants can be
rescued by knocking down the H3K36 methyltransferase, MES-4, which bookmarks germline genes for
reexpression in the germline of the next generation. These data suggest that the developmental delay that we
observe in the absence of SPR-5 and MET-2 is caused by ectopic expression of germline genes in somatic
tissues. Among the MES-4 regulated germline loci that are ectopically expressed in the soma of spr-5; met-2
mutants, we detect PIWI-interacting RNAs, or piRNAs, and the genes that regulate their function. piRNAs are a
large class of small non-coding RNAs that regulate development by functioning in several different pathways,
including epigenetic programming, germline transcript silencing, RNA turnover, and translational control. Ectopic
expression of piRNA genes has recently been implicated in somatic development and diseases, but how ectopic
piRNAs function in somatic cells or if they contribute to abnormal developmental phenotypes poorly understood.
Thus, our new C. elegans model provides a unique opportunity to molecularly demonstrate how ectopic germline
gene and piRNA expression affects normal development. By combining cutting-edge large genomic experiments,
classical developmental techniques, and single molecule fluorescent in situ hybridization we will use our C.
elegans model in AIM 1 to determine how ectopic germline genes alter somatic gene expression, 2) define tissue
specificity of ectopic germline gene expression, and 3) examine how distinct chromatin states contribute to
misexpression of germline genes in somatic tissues. In AIM 2, we will employ similar approaches to examine
how ectopic expression of piRNAs contributes to tissue specific somatic defects. Together, the proposed aims
will provide mechanistic insight into how these ectopic transcriptional events, that occur when histone modifying
enzymes are mutated, contribute to phenotypes that overlap with those seen in human neurodevelopmental
disorders.

Public health relevance
PROJECT NARRATIVE Data from mouse and human suggest a new disease paradigm where ectopic expression of genes and piRNAs when histone methylation is misregulated leads to developmental abnormalities. We have developed a C. elegans model that can be used to elucidate the mechanisms underlying this new disease paradigm. The proposed studies will take advantage of this new C. elegans model in which two histone modifying enzymes are mutated to determine how ectopic gene expression and ectopic piRNAs cause developmental defects.